A human monoclonal antibody therapy for treatment of hantavirus cardiopulmonary syndrome

PROJECT SUMMARY
Rodent-borne viral outbreaks are increasing in both frequency and impact. As weather patterns evolve, rodent
populations are affected and may multiply in areas where increased contact with humans results in infection.
Hantaviruses, including Andes (ANDV) and Sin Nombre (SNV), are transmitted through the excreta of infected
rodents and, when aerosolized, infect humans. In the Americas, hantavirus infection leads to hantavirus
cardiopulmonary syndrome (HCPS), a devastating condition that features rapid onset of pulmonary edema,
respiratory failure and cardiogenic shock. Treatment is supportive, not pathogen-targeted, and accordingly,
approximately 40% of patients do not survive. Because hantaviruses establish lifelong, asymptomatic
infections in their rodent reservoirs, they are highly prevalent in nature and represent a constant threat to
humans. For example, SNV is carried by the most abundant mammal in North America, the deer mouse, which
has a near ubiquitous distribution throughout the US and Canada. In the case of the South American ANDV, in
addition to rodent-to-human transmission, human-to-human transmission occurs, putting not only the patient,
but also family members and health care workers at risk. Despite this large potential for infection and the high
case fatality rate, there are no FDA-approved treatment options or vaccines available. Hantaviruses are thus
classified as NIAID Priority Pathogens and considered potential bioterrorism threats. Our long term goal is to
develop an effective therapeutic against HCPS-causing hantaviruses.
This proposal seeks to develop human neutralizing antibodies for therapeutic and/or prophylactic treatment of
HCPS caused by ANDV. We have assembled a multidisciplinary team of molecular virologists, clinicians, and
industry partners with experience developing antibody-based therapeutics. The successful development of a
potent neutralizing antibody against ANDV has the potential to be a first-line antiviral for the treatment or
prevention of HCPS.

Public health relevance
NARRATIVE Hantaviruses such as Andes virus (ANDV) and Sin Nombre virus (SNV) are rodent-borne viruses that cause highly lethal disease in humans. No approved drugs or vaccines exist to treat or prevent hantavirus infection. We will exploit proprietary technology and an experienced multidisciplinary team to develop potent neutralizing antibodies against ANDV. The successful development of this potent antibody-based therapeutic against ANDV has the potential to be a first-line antiviral for the treatment or prevention of hantavirus cardiopulmonary syndrome (HCPS).